1997 GORDON CONFERENCE ON DEVELOPMENTAL BIOLOGY

DESCRIPTION (Adapted from the applicant's description): The application requests funds for partial support of the 1997 Gordon Research Conference on Developmental Biology. This Gordon Conference will bring senior and junior scientists for discussions of the recent advances in the field of development and cell differentiation. The conference format will consist of short talks, followed by discussion, on topics ranging from cell fate determination and morphogenesis to cell signaling and gene regulation.